Tunable Assembly of Regulatory Immune Signals to Promote Myelin-specific Tolerance

During autoimmune disease, the body identifies and attacks “self” molecules. Current therapies are not curative
and require life-long compliance. Further, existing therapies – while beneficial, are broadly acting and can leave
patients immunocompromised. These challenges have sparked great interest in controlling autoimmunity with
vaccine-like specificity to preserve normal immune function. Both pre-clinical and clinical studies are testing this
idea in multiple sclerosis (MS), a disease that disproportionality impacts Veterans. MS is a neurodegenerative
disease driven by mistaken attack of myelin in the central nervous system (CNS). Thus, an experimental therapy
idea involves co-administration of myelin peptide and tolerizing cues to promote myelin-specific regulatory T
cells (TREG) that control MS. In some recent trials, small sets of 6-8 myelin epitopes are being tested as a route
to span the range of myelin reactivity in many - though not all - patients. Interestingly, one set of pathways newly-
associated with myelin-driven inflammation are toll-like receptors (TLRs). In healthy people, TLRs detect
pathogen-associated patterns to mobilize innate immunity. However, new work shows TLR signaling - such as
TLR9 - is elevated in MS patients and MS models (e.g., EAE, RR-EAE). In the latter, suppressing TLR9 function
reduces inflammation, while also promoting TREG and improving disease. Lymph nodes (LNs) and spleen are
key tissues that control polarization of myelin-reactive T cells toward either inflammatory T cells (e.g., TH17) or
TREG. Thus, strategies that guide T cell differentiating when myelin is presented in LNs – for example, co-delivery
of regulatory cues – could generate large populations of myelin-specific TREG that stop pathogenic immune cells
without broad suppression. Nanotechnology offers unique capabilities for this goal, including co-delivery of self-
antigen and regulatory cues, targeting, and tunable release. However, many polymer particles and other
biomaterials exhibit intrinsic features that trigger inflammatory signaling, which could exacerbate autoimmunity.
Strategies that mimic attractive features of biomaterials, while eliminating inflammatory “carrier” effects could be
transformative for new therapies for MS. This Renewal VA Merit application uses polyionic immune signals to
advance novel nanostructured capsules built entirely from regulatory immune cues and myelin antigen. These
immune polyelectrolyte multilayers (“iPEMs”) are assembled through electrostatic interactions on a template,
which is removed to leave capsules that juxtapose myelin with a regulatory TLR ligand against TLR9 (GpG).
Since there is no carrier, the density of signals in iPEMs is very high relative to polymer or lipids encapsulating
cargo (e.g., nanoparticles). During the initial award, this high density juxtaposition of self-antigen and regulatory
cue (GpG) was shown to promote differentiation of myelin-specific T cells toward TREG and away from
inflammatory T cells. Likewise, pilot studies with MS patient samples reveal myelin/GpG iPEMs restrain myelin-
driven inflammation. In relapsing-remitting (RR-EAE) and progressive (EAE) models of MS, iPEMs reverse
disease-driven paralysis. With continued VA support, this project will generate the remaining pre-clinical data
needed to motivate future clinical development of a therapy that could offer Veterans and their families a safe
and effective vaccine-like immunotherapy for MS. The broad goal is to define the role of TLR signaling in T cell
polarization and efficacy, and show these effects are durable and robust across disease models and a set of
existing, de-identified male and female Veteran MS patient samples. Our plan is supported by a multidisciplinary
team of bioengineers, immunologists, and MS clinicians with a history of effective collaboration on this and other
projects focused on antigen-specific tolerance. The specific aims are 1) Confirm iPEMs alter TLR signaling &
function in APCs and link changes to T cell polarization, 2) Define iPEM-driven structural and functional changes
associated with tolerance in LNs & spleen, 3) Ascertain the durability of efficacy and changes in CNS pathology
during EAE/RR-EAE, 4) Show iPEMs regulate TLR signaling & antigen-specific response in MS patient samples.

Public health relevance
Multiple sclerosis (MS) occurs when the immune system mistakenly attacks myelin in the brain, leading to loss of motor function. MS affects a large number of Veterans and no cure exists. Further, existing treatments are not specific and can leave patients immunocompromised. The need for life-long treatment also creates a large burden on patients and families. The goal of this project is to use nanotechnology to control signal processing in lymph nodes, tissues that regulate immune function. This ability could promote regulatory immune cells that specifically control the inflammatory cells attacking myelin. This advance would benefit Veteran’s health in three ways. First, myelin-specific tolerance that controls disease without hindering healthy immunity would improve efficacy and Veteran quality of life. Second, generating long-lasting regulatory cells would enable less frequent treatments, improving patient compliance and reducing the burden of managing disease. Lastly, since treatments might provide permanent improvements, healthcare costs for Veterans and families could be greatly reduced.